Investigating cognitive-motor variability to predict driving performance in stroke survivors with MCI

PROJECT SUMMARY/ABSTRACT
Dr. Neha Lodha is an Assistant Professor in the Department of Health and Exercise Science at Colorado State
University (CSU). Dr. Lodha's long-term career goal is to become an independent investigator advancing the
science of functional mobility to improve the quality of life in aging and age-related neurological disorders and
dementias. Up to this point, Dr. Lodha has acquired strong scientific background in neurophysiology and motor
control. To accomplish her career goal, a key additional element required is the training in cognitive sciences.
Understanding how cognitive and motor systems interact to enable independent mobility is important for
identifying the precise mechanisms and developing interventions to promote functional mobility. The short-term
training goals of the current K01 application are to train in 1) conducting cognitive assessments with specific
emphasis on the intra-individual variability (IIV) approach, 2) clinical trials design and analysis, 3) multivariate
statistics, 4) driving technology, and 5) transition to independence. To achieve these goals, Dr. Lodha has
assembled a mentoring team that consists of 1) an eminent gerontologist, Dr. Manfred Diehl (primary mentor)
with expertise in aging, IIV and cognitive development across the lifespan, 2) an experimental psychologist, Dr.
Karlene Ball (co-mentor) who is internationally renowned for her work in cognitive correlates of driving mobility
in aging and dementia, 3) a vascular neurologist, Dr. Sharon Poisson (advisor) with extensive experience in
clinical trials in stroke survivors, and 4) a renowned biostatistician, Dr. Haonan Wang (co-advisor) with
experience in statistical inference and modeling for clinical data. The proposed research plan focuses on
identifying the motor and cognitive impairments underlying driving deficits in older stroke survivors with mild
cognitive impairment as they are most likely to resume on-road driving after stroke. Conventionally, driving
impairments are shown to be independently influenced by mean-level performance in specific motor and
cognitive domains. However, this mean-level approach neglects the well-established fact that performance
becomes highly variable and unstable in older adults with neurological disorders, such as those at preclinical
stages of Alzheimer's disease and mild cognitive impairment. The proposed research will apply the novel intra-
individual variability (IIV) approach to investigate driving mobility in older stroke survivors. The goal of the
research plan is to identify the impact of stroke on IIV in motor and cognitive performance (Aim 1); determine the
contribution of IIV measures to predict driving performance (Aim 2); and use IIV measures to predict change in
driving performance over a two-year period (Aim 3). The training plan will accelerate Dr. Lodha's career to pursue
a unique and independent line of research that combines cognitive and motor processes to promote the
functional mobility of older adults and is directly aligned with NIA's AD/ADRD goal to identify sensitive behavioral
measures for earliest manifestations of functional impairments in older adults.

Public health relevance
PROJECT NARRATIVE The ability to drive a car safely is critical for older adults to maintain functional independence and is often compromised when age-related neurological disorders occur. The proposed studies will pioneer the investigation of behavioral fluctuations in motor and cognitive performance to identify and predict driving deficits in stroke survivors with mild cognitive impairment. This research will lay the groundwork to identify sensitive, behavioral markers that provide early detection of decline in driving function.